Understanding individual- and social network-level factors affecting infant HIV testing to design social network interventions to increase testing of HIV-exposed infants

PROJECT SUMMARY/ABSTRACT
More than one million infants are exposed to HIV each year in high-burden sub-Saharan African countries. Yet
only 60% of HIV-exposed infants are tested as recommended by two months of age. The key barriers to infant
HIV testing – stigma/non-disclosure, lack of access and poor social support – may be more effectively
overcome through interventions that engage women's social networks, the patterns of relationships women
have with family, peers, and other community members. Social networks make salient contextual norms and
enable peer learning, social support, and social engagement, all of which can affect health behaviors. There
remains a scientific gap in applying social network analysis to infant HIV testing. Until this gap is addressed,
there will also remain an implementation knowledge gap on how to design interventions that engage social
networks to prompt infant HIV testing. The central hypothesis of this proposed grant is that social networks can
influence women's decisions to test their infants for HIV. The primary objective of this K01 application is to
understand how women's individual- and social network-level characteristics affect infant HIV testing to design
and assess the feasibility of a social network intervention to improve infant HIV testing. The approach
leverages the infrastructure from an ongoing longitudinal study (R01MH113494, PI: Tsai) with complete social
network data from all adults living in 8 villages of Mbarara, Uganda and extends new primary data collection to
all HIV-positive, reproductive-age women and their children born during the study period. The grant will
achieve the following specific aims: 1) estimate individual- and social-network level correlates of infant testing
through social network analysis exploring the roles of peer influence, social norms, social support and social
engagement; 2) conduct in-depth qualitative interviews among women and integrate findings with quantitative
data to understand how social network mechanisms affect infant testing and develop a conceptual framework
of infant testing; 3) design and assess feasibility, acceptability, fidelity, reach and preliminary effectiveness of a
social network intervention to prompt infant HIV testing. My long-term goal is to become an independent
researcher with expertise in developing social network interventions to enhance HIV treatment and prevention
among women and children in sub-Saharan Africa. This K01 proposal will supplement my prior training and
experience with additional training and mentorship from a team of senior researchers with expertise in social
networks, qualitative and mixed methods, and implementation science applied to the context of HIV. I will
obtain integrated training, mentorship, and preliminary data for an R01 proposal to empirically test a novel
intervention to overcome the public health problem of low infant HIV testing. The key innovation of this
proposed study is that it is one of the first to apply social network theory and analysis to infant HIV testing. This
contribution will have significant public health impact by increasing uptake of HIV testing for the nearly one half
million exposed/undiagnosed infants in sub-Saharan Africa who are not tested by two months of age.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because progress to ensure that all HIV-exposed infants are tested and treated as necessary has lagged and, without substantial improvements, will prevent the global community from reaching the UNAIDS 90-90-90 targets to end the AIDS epidemic by 2030. There is an urgent need for novel approaches to prompt early infant HIV testing, such as engaging social networks since they have been shown to be important in affecting other health behaviors, though not yet rigorously assessed within the context of infant HIV testing. This proposed research is directly relevant to NIH's HIV/AIDS research priorities to develop, test, and implement strategies to improve HIV testing by laying the foundations for implementing a social network intervention to ensure prompt testing and treatment for the 150,000 newly infected infants each year.